Medical Scientist Training Program

PROJECT SUMMARY/ABSTRACT
The mission of the Medical Scientist Training Program (MSTP) of the Albert Einstein College of Medicine is to
train physician-scientists who will become future leaders in biomedical and clinical research. The MSTP strives
to recruit a diverse group of outstanding students. It provides them with rigorous integrate medical and
research training that prepares them for careers as physician-scientists. Through a flexible and continously
evolving curriculum that includes 1) specialized MSTP courses and 2) integration of graduate and medical
school curriculum in the first 2 years, the students are guided through a program that can be tailored to meet
their individual needs and interests. The progam seeks to provide the trainees with a solid foundation for
careers as independent physician-scientists and to facilitate their placement into outstanding postgraduate
training programs to facilitate the next step in their career progression. The training program has 3 phases. In
the first 2 years students take an integrated combination of medical, graduate and MSTP-specific courses to
provide the didactic foundation for their reseach and clinical training. They perform research rotations to assist
them in choosing their thesis research lab. In the program's 2nd phase, they perform independent, original
research under their mentor's guidance. They publish their discoveries in high quality peer-reviewed papers,
and prepare and defend a PhD thesis. Participation in an evening, MSTP-run, ambulatory outpatient clinic
allows them to build their clinical skills during the PhD phase of the program. In the final phase, they complete
their clinical training on the wards. We are developing a longitudinal learning experience to foster rigor and
reproducibility in the research performed by MSTP students. The admissions process seeks to identify
individuals with the intelligence, curiosity, creativity, resilience, perseverence and enthusiam for science that is
essential for future success in a research career. Currently, 103 trainees are in the program, 37% are woman
and 25% are members of underrepresented minorities. We plan to expand the program to a steady state size
of ~120-130 trainees by increasing the size of our entering class to 16. Since its inception in 1964, as one of
the first three NIH funded MD-PhD training programs, 425 trainees have graduated. 346 have completed
postgraduate training and published over 18,000 papers, an average of 53 papers per graduate. 74% have
jobs at academic medical centers, research institutes, NIH or pharmaceutical companies. By various
measures, the program graduates have achieved outstanding success in their chosen careers. They have
advanced biomedical research and academic medicine. Based on the quality of our past accomplishments and
the new developments in biomedical research, we propose to evolve the program, to further integrate graduate
and medical training, and increase opportunities for involvement in clinical and translational research in order
to prepare a future generation of physician-scientists who will be at the leading edge of biomedical research
with the ultimate goal of improving human health and reducing the burden of disease.

Public health relevance
PROJECT NARRATIVE Physician-scientists perform a critical role at the interface between basic biomedical research and clinical medicine. This program will train a diverse group of outstanding students and prepare them to enter the biomedical research workforce as physician-scientists who will perform basic, translational, and clinical research. This research will lead to new treatments to prevent or cure disease and improve the health of all Americans.